High-end MALDI Time of Flight Mass Spectrometer for Bioanalysis

PROJECT SUMMARY
Mass spectrometry (MS) is an essential tool to support biologically and biomedically related research at Arizona
State University (ASU). In 2018, ASU has centralized its mass spectrometry services in a core facility that serves
over 100 researchers throughout ASU and surrounding academic and biotechnology entities. ASU is proud of
having been recognized as #1 in innovation for the 6th time in a row by US News, but to hold this status and
serve the needs for the ASU research community and its students, core and support facilities need to meet the
requirements of the next generation cutting-edge research environment. The MS Core Facility at ASU is centrally
located in the Biodesign Institute, a forerunner of biological and medical invention focusing on societal problems
such as for example a saliva based COVID-19 test that was made available to the Arizona public during the
ongoing pandemic. ASU and the Biodesign Institute also thrive as a top research institution for biomolecular
structure elucidation to unlock key biomolecular details responsible for biological and medical processes involved
in metabolism and diseases such as cancer and neurodegenerative disorders. Researchers at ASU also strive
in gaining biomolecular signatures important to understand energy conversion and photosynthesis to solve our
and future generation’s energy needs. In addition, the School of Molecular Sciences at ASU has among its
faculty members talented young and established researchers that take molecular sciences to the next level with
innovative synthesis approaches. All these areas require reliable and flexibly accessible structure elucidation
tools, which in many cases is accomplished or supplemented through matrix assisted laser desorption ionization
(MALDI) MS. However, the MS core facility at ASU only owns one rather basic MALDI MS instrument, which we
intend to supplement through the current proposal with a more sensitive and higher resolution instrument also
capable of MALDI imaging. With this new MALDI MS instrument we will upgrade the available MS analysis
capabilities at ASU to meet the needs of our currently funded NIH researchers but also provide a tool paving the
way for the next generation of research projects facilitated through high end mass spectrometry.

Public health relevance
Project Narrative The requested mass spectrometer will support critical research that is important for the future of our society. Understanding the detailed structure and mechanisms with which proteins and other biomolecules interact and fulfill important biological functions will be critical in fighting maladies such as neurodegenerative diseases, cancer and infectious disease outbreaks but also in solving our society’s future energy needs. All researchers involved in this instrument proposal work on the forefront of science advances critically propelling our detailed biological knowledge.